Administrative Core

The goal of the Administrative Core is to provide scientific leadership and organizational support to facilitate the research collaborations outlined in the application. This will be accomplished through five specific aims. Provide scientific leadership to program participants and monitor timelines to ensure progress. II. Provide coordination and facilitate interactions among all program participants. . Recruit Scientific Advisory Board members and coordinate annual meetings. IV. Provide fiscal and contractual management to ensure efficient interactions among participant institutions. V. Provide administrative support for program activities including report preparation, intellectual property filings, publications, meeting arrangements and data sharing.

Public health relevance
RELEVANCE (See instructions): Finding a vaccine for HIV is probably one of the most important goals of biomedical research. SIV challenge of vaccinated Indian rhesus macaques is one of the best defined models available for pre-clinical development of HIV vaccines.